Covalent Chemistry on Nanosubstrates Enables Molecular Analysis of Purified Extracellular Vesicles in Hepatocellular Carcinoma

PROJECT SUMMARY
Extracellular vesicles (EVs) are a heterogeneous group of phospholipid bilayer-enclosed particles with the
biomolecular contents mirroring those of their parental cells. Since EVs are present in circulation at a relatively
early stage of disease and persist across all disease stages, purification and characterization of tumor-derived
EVs are expected to offer an opportunity for early cancer diagnosis. Hepatocellular carcinoma (HCC), the
fourth most common cause of cancer-related deaths worldwide, is in dire need of diagnostic and prognostic
biomarkers. Current clinical radiographic system and serum biomarkers (e.g., alpha-fetoprotein (AFP)) poorly
discriminate early-stage HCC (where potentially curative therapies are available) from at-risk liver cirrhosis
(where HCC surveillance is indicated). Moreover, sensitive biomarkers for HCC postoperative recurrence
(where timely salvage treatment interventions can suppress disease progression) after curative-intent liver
resection and liver transplantation remain a significant challenge for early-stage HCC. Therefore, exploiting the
diagnostic potential of HCC EVs and EV cargo profiling for HCC early detection and postoperative recurrence
holds great promise to significantly augment the ability of current diagnostic modalities.
Conventional methods for isolating EVs, such as ultracentrifugation, filtration, and precipitation, are incapable
of discriminating tumor-derived EVs from non-tumor-derived EVs. To address this unmet need, our team
developed “EV Click Chips” for HCC EV purification. The innovation of our devices includes i) the covalent
chemistry-mediated EV capture/release couples click chemistry-mediated EV capture and disulfide cleavage-
driven EV release, ii) an optimized multi-marker cocktail targeting HCC-associated surface markers was
adopted to overcome the heterogeneity of HCC EVs; iii) the incorporation of densely packed silicon nanowire
substrates (SiNWS) dramatically increases the device surface areas for contacting/interacting with EVs; and
iv) the microfluidic chaotic mixer facilitates repeated physical contact between SiNWS and the flow-through
EVs, further enhancing the performance of EV purification. The purified HCC EVs can be characterized by
quantifying a panel of 10 well-validated HCC-specific mRNA markers by incorporating Droplet Digital PCR
(ddPCR) technology. The proposed research will conduct: i) an exploratory development and optimization of
EV Click Chips for HCC EV purification, and ii) clinical validations of EV Click Chips for HCC early detection
and postoperative recurrence using patient blood samples. Our long-term goal is to develop a new HCC EV
purification system (i.e., EV Click Chips) by synergistically integrating four very powerful approaches, including
covalent chemistry-mediated EV capture/release, multimarker antibody cocktails, nanostructured substrates,
and microfluidic chaotic mixers. The purified HCC EVs will readily allow for quantitative cargo profiling to
augment current HCC diagnostic algorithms.

Public health relevance
Project Narrative Among the different tumor liquid biopsy approaches, extracellular vesicles (EVs) are present in circulation at a relatively early stage of disease of hepatocellular carcinoma (HCC). The long-term goal of this R01 proposal is to develop a new HCC EV purification system (i.e., EV Click Chips) by synergistically integrating four very innovative approaches. The successful development of the proposed EV Click Chips will enable more sensitive and specific HCC EV-based molecular assays for HCC surveillance and will be rapidly translatable to the fields of oncology and cancer biology.